Human-centered CT-based CADx Tools for Traumatic Torso Hemorrhage

Trauma is responsible for 180,000 deaths annually in the United States and accounts for 59% of deaths in the
population younger than 45 years. 86% of preventable deaths are related to sequalae of massive torso
hemorrhage. Rapid precision diagnostic tools are needed to triage patients for early activation of massive
transfusion protocols and urgent surgical or angiographic hemostatic intervention to circumvent the vicious
cycle of acidosis, coagulopathy, hypothermia, and death resulting from exsanguination. Whole-body CT
angiography (WBCTA) is the workhorse screening and surgical planning modality for torso hemorrhage. Lethal
but preventable hemorrhage typically arises from pelvic fractures and organ lacerations, manifesting on
WBCTA as foci of contrast extravasation and pooled cavitary hemorrhage (e.g., pelvic hematoma, hemothorax,
or hemoperitoneum). Rapid assessment of WBCTA can result in earlier intervention, with associated survival
benefit, but interpretation delays are common and increase with severity of injury, transfusion requirement, and
mortality risk due to the increasing complexity of polytrauma. Round-the-clock expertise in trauma imaging is
concentrated in select high-volume level I trauma centers, and community or teleradiology practices may lack
experience interpreting trauma WBCTA studies. Clinical indices such as the Shock Index have limited
sensitivity as screening tools for forecasting actionable hemorrhage-related outcomes. WBCTA computer
aided diagnosis (CAD) tools that detect bleeding pelvic fractures and organ lacerations, classify severity grade,
and deliver precise voxelwise volumetric measurements of multicavitary hemorrhage burden will accelerate
and standardize image analysis, reduce turnaround time for reporting of critical results, improve the accuracy
and objectivity of clinical decision making, and ultimately reduce time to life-saving hemorrhage control
interventions. To capitalize on the benefits of point-of-care CT-based CAD tools in the fast-paced, and safety
critical trauma care setting, such tools must be rapid, accurate, generalizable, and elicit a high level of end-
user trust. To minimize bias, ensure clinical utility, and maximize robustness for turn-key deployment in future
multicenter clinical trials, tools must scale to large diverse populations, and achieve human factors engineering
goals established through expert target user input. Our team will bring to bear combined technical and clinical
expertise in trauma radiology, medical image processing, and human-centered software design to create an
orchestrated suite of rapid, accurate, clinically relevant, and user-centered CAD tools for torso hemorrhage. In
Aim 1, we will leverage AI-assisted annotation to curate a uniquely large dataset of consecutive admission
trauma WBCTAs. In Aim 2, we will use human-centered design principles to develop a suite of interactive high-
trust CAD tools. In Aim 3, we will assess generalizability with a large out-of-sample dataset and assess user
acceptance with simulated deployment. The work will result in rapid, robust, and human-centered CAD tools
for detection, precision diagnostics, and personalized decision support for hemorrhage-control interventions.

Public health relevance
PROJECT NARRATIVE: Up to 86% of preventable deaths after trauma are related to sequelae of multicavitary hemorrhage in the non-compressible torso. Whole-body CT angiography (WBCTA) is routinely performed on trauma admission as a screening and surgical planning tool and is associated with a survival benefit, however interpretation delays contribute to delays to transfusion and surgical or angiographic hemostatic intervention. High-trust human-centered computer-aided detection and diagnosis (CAD) tools for screening, hemorrhage burden quantification, and personalized decision support will accelerate and standardize image analysis of torso hemorrhage.